Engineering bacterial group I introns for efficient production of safe and durable nucleoside-modified circular mRNA therapeutics

PROJECT SUMMARY
Synthetic messenger RNAs (mRNAs) represent a new class of biopharmaceuticals with broad clinical utility for
a range of diseases. The incorporation of chemically modified uridine nucleosides, pseudouridine (Ψ) and N1-
methylpseudouridine (m1Ψ), significantly reduces synthetic mRNA immunogenicity. Linear nucleoside-modified
mRNAs are short-lived because they are susceptible to cellular exonucleases, hindering their broad clinical utility
for a range of diseases. Synthetic circular mRNAs (circRNAs) evade cellular exonucleases, resulting in a longer
half-life, but efficient circularization methods are incompatible with chemical modifications. The most efficient
method of RNA circularization utilizes self-splicing group I introns. Proper folding—and thus activation—of the
typical group I intron is disrupted by Ψ-modified nucleotides. A survey of self-splicing introns, however, identified
a compact group I intron from the cyanobacterium Azoarcus that effectively circularizes short (~150 nt) Ψ-
modified RNA. The Azoarcus intron can circularize long (~2000 nt) unmodified mRNA but not long Ψ-modified
RNAs. This proposal seeks to test the hypothesis that Ψ and m1Ψ prevent circularization by disrupting tertiary
interactions required for rapid and efficient intron splicing and to develop efficient circularization techniques
compatible with Ψ and m1Ψ for safe and stable RNA therapeutics. Aim 1 will determine how uridine modifications
affect the structure of Azoarcus group I intron. High throughput structural probing will be used to study how
uridine modifications stabilize inactive conformations of the Azoarcus group I intron. Aim 2 will employ in vitro
evolution to identify Azoarcus group I intron variants optimized to circularize Ψ and m1Ψ-modified RNA. The Ψ-
and m1Ψ-modified circRNA will be tested in immune cells for their ability to induce an immune response. This
study will provide structural insights into how nucleoside modifications change RNA structure and function and
develop a straightforward methodology to prepare nucleoside-modified circular mRNAs, expanding the potential
uses of mRNA therapeutics beyond vaccines. In addition, the proposed research will provide training in high-
throughput sequencing, in vitro biochemistry, cellular RNA sensing, nucleic acid chemistry, and structural biology
to prepare the fellow for a career as an independent investigator developing next-generation mRNA therapeutics.

Public health relevance
PROJECT NARRATIVE Therapeutic mRNAs promise to transform medicine by enabling the prevention and treatment of infectious and genetic diseases, including those that lack traditional drugs. This proposal seeks to combine two technologies that improve the safety and durability of therapeutic mRNA.